Thioesterase-mediated lipotoxicity in liver and thermogenic adipose tissue

PROJECT SUMMARY/ABSTRACT
Obesity-induced lipotoxicity is the primary pathophysiological defect that predisposes to non-alcoholic fatty liver
disease (NAFLD). Because current management options remain limited, identification of new regulatory
mechanisms that govern the maladaptive response to overnutrition will serve to identify novel opportunities for
pharmacologic intervention. Acyl-CoA thioesterases (Acots) control the cellular utilization of fatty acids by
hydrolyzing acyl-CoA into non-esterified fatty acids. Our long-term goal is to define how aberrant Acot activity
can be leveraged for therapeutic purposes. The objective of this research is to determine the mechanisms by
which Acot9-mediated hydrolysis of acetyl-CoA culminates in metabolic disease. Our preliminary data indicates
that Acot9 locates to the inner membrane (IM) of the mitochondria in the liver where it traffics acetyl-CoA
towards the citric acid (TCA) cycle. This results in increased hepatic glucose production (HGP) and de novo
lipogenesis (DNL) as well as lipotoxicity as evidenced by reactive oxygen species (ROS) and hepatic insulin
resistance. In addition to TCA cycle, Acot9 increased acetyl-CoA supply for lysine acetylation of proteins (AcK)
by controlling acetyl-CoA bioavailability and by inhibiting the deacetylase sirtuin 3 (Sirt3), which reduces ROS
by inhibiting AcK. In contrast to liver, in thermogenic adipose tissue (BAT), cold-induced translocation of Acot9
from IM into mitochondrial matrix suppressed thermogenesis by trafficking acetyl-CoA away from TCA cycle.
Our central hypothesis is that obesity-induced activation of Acot9 impairs nutrient homeostasis by promoting
lipotoxicity in the liver and by limiting thermogenesis in BAT. The rationale is that the mechanisms of acetyl-
CoA trafficking by Acot9 will reveal novel targets for the prevention of lipotoxicity and its pathophysiological
consequences. The central hypothesis will be tested in three specific aims: 1) To identify the molecular
mechanisms by which hepatic Acot9 promotes hepatic lipotoxicity; 2) To elucidate the mechanisms by which
Acot9 in BAT limits thermogenesis; and 3) To determine the mechanisms by which Acot9 controls AcK and
ROS in the liver. In Aim 1, the mechanisms of Acot9-induced lipotoxicity, HGP and DNL will be elucidated in
mice with liver-specific ablation of Acot9 (Acot9LKO) using lipidomics and metabolomics. Impact on insulin
signaling and lipotoxic pathways will be determined in mice and primary hepatocytes. Aim 2 will use mice with
BAT-specific ablation of Acot9 for the indirect calorimetry measurements in climate-controlled cages. Clamp,
tissue histology and metabolomics will assess the metabolic function of Acot9 in BAT. Cultured brown
adipocytes and recombinant Acot9 will be used to determine the mechanism of Acot9 translocation into
mitochondrial matrix. Aim 3 will use Acot9LKO/Sirt3–/– double knockout mice to determine the role of Sirt3 in
Acot9-mediated regulation of AcK and ROS in the liver. Overall, this proposal will elucidate new mechanisms
of thioesterase-mediated control of acetyl-CoA utilization. This is significant because acetyl-CoA is the
common breakdown end-product of nearly all dietary lipids and sugars. These studies are expected to
establish Acot9 as a tractable target for the management of NAFLD.

Public health relevance
Project Narrative The proposed studies will examine the mechanism by which a novel protein regulates hepatic lipid and glucose metabolism. This research is relevant to public health because it is anticipated that the results will improve our understanding of the relationships between obesity and metabolic disorders. The proposed studies are relevant to the mission of the NIDDK because they are expected to identify new therapeutic approaches for the management of common disorders related to excessive lipid accumulation.